Administrative Core

The Administrative Core, led by the Center Director, Dr. Amy S. Paller, and the Associate Center Director, Dr.
Robert M. Lavker, will be responsible for coordinating all activities of the SBDRC. The Administrative Core will
serve as a focal point for all University-wide cutaneous biology-related activities via an Enrichment Program
that organizes seminars, workshops, lectures, and one-on-one interactions with distinguished visiting
scientists. The Administrative Core will also maintain the SBDRC website and disseminate electronic
communication, including through a twice yearly newsletter and use of social media. The Core will continue to
encourage investigators to enter the skin biology field through the administration of a Pilot & Feasibility
Program that funds four P&F grants per year. Through the management of the Minority and Sex Awareness
Program, the Administrative Core hopes to: (i) promote a better understanding of the biology of all human skin;
and (ii) attract and recruit under-represented minorities and women into cutaneous research. To this end, we
have prioritized choosing at least one P&F grant that involves comparison between sexes or racial/ethnic
groups or a problem that disproportionately affects one sex or a minority population. The Administrative Core
will regularly review the other Research Cores (Skin Tissue Engineering and Morphology/STEM, Translational
and Experimental Skin Testing and Immune Tracing/TEST IT, and Gene Editing, Transduction and
Nanotechnology/GET iN) to assure quality, fiscal responsibility, and continued development of new services.
The Core will also oversee all fiscal maintenance of Center resources, including service cost calculations and
ensuring an overall balanced budget. The Administrative Core will accomplish all of these takes with guidance
from: (i) the SBDRC Executive Committee; (ii) an Internal Advisory Board; and (iii) an External Advisory Board.
Finally, the Core will continue to foster the training of young scientists in the field of skin biology and skin
diseases through the continued mentorship of our junior members by the senior SBDRC bench research
members and Board members.